Better options for chronic cancer pain: a SMART study

Background: Twenty-four percent of Veterans who survive cancer remain on long term opioid therapy (LTOT)
after completing cancer treatment, placing them at significant risk of opioid addiction, overdose, and other opioid-
related health conditions. To reduce opioid use in this population, we will examine the impacts of multimodal
pain care and buprenorphine rotation – two strategies that have demonstrated efficacy in Veterans with
musculoskeletal pain on LTOT but have not been tested in cancer survivors on LTOT, revealing a critical
knowledge gap. The overall scientific premise of this project is that these two approaches can effectively reduce
LTOT in cancer survivors without worsening chronic pain, and that they are better than pain medication
optimization and opioid tapering. Our primary objective is to examine which treatment strategy or combination of
strategies is most successful at achieving a reduction in LTOT without worsening chronic pain over 6 and 9
months. We will also identify the key challenges and strategies in the implementation of each treatment strategy
to facilitate future translation of study findings into VA practice.
Significance: There are currently no care pathways at the VHA to help cancer survivors on LTOT find
alternatives to opioids for managing chronic pain, nor evidence to guide which interventions to include. By
addressing these unmet needs, this work aligns with POU-AMP’s priority to examine clinical interventions for
tapering opioid medications.
Innovation: We are among the first to examine multimodal care and buprenorphine rotation to reduce LTOT in
cancer survivors. Also, we are among the first to apply VHA’s evidence-based, stepped care model of
multidisciplinary pain care to cancer survivors on LTOT.
Aim 1: To test if Veterans who receive multimodal pain care will be more likely to decrease total daily opioid use
by at least 20% at 6 and 9 months without experiencing worsened pain interference compared to those who
receive optimization of non-opioid pain medications.
Aim 2: To test if Veterans who do not respond to 6 months of multimodal care or medication optimization are
more likely to achieve the desired outcome at 9 months when they are offered buprenorphine rotation as opposed
to opioid tapering.
Exploratory Aim 3: To examine which combination of interventions is most likely to achieve the desired outcome
at 9 months.
Aim 4: To understand the key challenges and strategies in the implementation of each intervention to facilitate
future translation of study findings into practice.
Methodology: We plan a two-site, two-stage, response-adaptive, comparative effectiveness trial following
SMART (Sequential, Multiple-Assignment Randomized Trial) principles. We will enroll 294 Veteran cancer
survivors on LTOT who receive their care at the Indianapolis or Ann Arbor VAMC. Subjects will be randomized
to either multimodal pain care or pain medication optimization at Stage 1. After 6 months, non-respondents will
be randomized to buprenorphine rotation or opioid tapering in Stage 2. Our primary outcome is a composite
variable combining one objective outcome (opioid dose reduction) and one subjective outcome (pain
interference), assessed at 6 and 9 months. Our secondary outcomes are opioid dose reduction and pain
interference individually.
Next Steps/Implementation: Successful execution of this project will provide actionable information, including
an implementation strategy, that VHA’s Offices of Pain Management and Oncology can put in place to support
over 240,000 cancer survivors on LTOT for chronic pain.

Public health relevance
This proposal is relevant to the 240,000 cancer survivors who continue to use opioids long after they have successfully completed treatment for cancer at the VHA, placing them at risk of opioid addiction and overdose, and other opioid-related problems. Yet, there are no programs at the VHA to help them find alternatives to opioids, nor evidence to inform the choice of interventions. This study will meet these needs by examining four interventions that are effective at reducing opioid use in patients with chronic musculoskeletal pain but have yet to be tested in cancer survivors on long term opioid therapy. The proposed work is relevant to the VHA Pain Office’s mission to provide Veterans better pain management while limiting the risks of long-term opioid therapy and it aligns with VHA Research and Development’s priority to examine clinical interventions for tapering opioids. Successful completion this project will keep VHA at the forefront of the battle against the opioid epidemic with a strategy that may be adapted to address the same needs in non-Veterans.